Temporal Coding and Palatability in Gustatory Cortex

Project Summary/Abstract
We like to think of taste as working relatively simply—a sweet taste is recognized as sweet by
virtue of activating certain cells on the tongue, and that information is used to drive neurons that
cause us to eat more of whatever food is in our mouths. The truth, however, is much more
interesting: a taste hits the tongue, and complex circuits in the brain go into action, passing
food-related information back and forth as the system as a whole decides whether the morsel is
palatable enough to swallow. My lab studies this process by recording from multiple parts of the
taste system while active rats are sampling various tastes. We have observed this decision-
making process in action in taste cortex, where neural ensembles report, in turn, that a taste is
on the tongue, that the taste is (say) sugar, and that it (the rat) currently likes the taste; this last
step appears to be one arrived at suddenly, in a moment of insight—the food rolls around in the
rat’s mouth for 0.5-1.5 seconds, and then the decision is made. This process clearly involves
and requires cortex, but it is just as clear that cortex doesn’t work alone. Here, we will do
rigorous tests of where that information in cortex comes from (specifically examining the roles
played by amygdala and hypothalamus), in the process revealing novel systems-level
mechanisms of taste processing. As a whole, this research project has the potential to
completely change the way we think about taste, and to usher in new thinking about perception
in general—thinking that makes a great deal more biological sense, given the complexity of
brain circuitry.

Public health relevance
Project Narrative When a taste is placed on our tongues, we must recognize that a taste is on the tongue, identify that taste, decide whether it’s palatable or not, and then either swallow it or expel it. This thought process can be observed to play out in the firing of neurons in taste cortex, but evidence suggests that cortex doesn’t work alone. We will rigorously test how the amygdala (the seat of emotion in the brain) and hypothalamus (the center that controls hunger and thirst) work with cortex, and with one another, to make taste decisions happen, and how these decisions get implemented by motor circuits—adding to a systemic understanding of taste that will help us fight against a spectrum of feeding-related disorders.